Elucidating the Orchestrated Bacterial Response to Copper Toxicity

PROJECT SUMMARY
Metal dysbiosis is detrimental to any living system as approximately 40% of proteins use metals as a cofactor
or structural component. Therefore, when pathogenic bacteria invade a host, there is a battle for metal
micronutrients such as iron, calcium, manganese, and zinc that benefit each organism. While the human host
acquire metals through their diet, bacteria must acquire metals from within the host. However, for bacteria that
exist at the host/pathogen interface, some host utilized metals can be toxic to bacteria. For example, compared
to the concentrations of iron, calcium, and manganese needed for survival, zinc and especially copper are toxic
to bacteria even at lower concentrations. As such, bacteria have evolved import and export systems to
maintain homeostasis. Complicating metal acquisition is mismetallation, when the unintended metal binds to
the protein to diminish function (e.g., low enzymatic turnover or decrease substrate binding), specifically
because the stability of complex formation with divalent metal is as follows, Cu >Zn > Fe > Mn > Ca. To restrict
infection, the human host sequesters beneficial metals (iron, calcium, and manganese) while also bombarding
the bacteria with zinc and copper. How bacteria respond to copper + zinc stress and the different
concentrations of these metals they encounter in the host are largely unknown. While metal toxicity has been
the subject of other studies, most of these have focused on single concentrations of one metal and often in
complex media. These media are more lavish than the host environment and may mask portions of the metal
response. To address fundamental gaps in knowledge regarding how bacteria respond to metal dysbiosis, we
used a multi-omics approach (transcriptomics and metabolomics) to investigate the pathways affected during
bacterial disruption via copper and zinc at varying concentrations in a host-adjacent, minimal, and defined
media in Streptococcus pneumoniae as the bacterial system. Using these data and leveraging our technical
expertise in metallobiology and microbiology, we will determine how metal influx, efflux, and internal metal
concentrations (the “metallome”) respective to copper and zinc affect the transcriptome and metabolome.
These data will not only be used to determine which systems are affected, but also when these systems are
being turned on respective to concentration dependence. We will determine how some of these systems are
being regulated based on mismetallation of proteins such as DNA transcription factors. We will determine how
metal dysbiosis affects other metal transport. Lastly, we will determine if an affected system is poisoned by
copper and/or zinc or being used to overcome that stress based on examining the metabolite level respective
to the direction of the system’s transcriptomic profile.

Public health relevance
NARRATIVE While metal toxicity is broadly toxic to bacteria, how they respond to this toxicity and the order in which they do so remains unknown. This project will explore the effects of copper and zinc overabundance on Streptococcus pneumoniae to elucidate bacterial systems used to respond to metal stress, how the bacteria enact that response, and which systems are targets of metal stress.